Epigenetic mechanisms of positive affective state of AUD

Project Summary/Abstract
The withdrawal syndrome of alcohol use disorder (AUD) includes both negative symptoms, like
anxiety, and motivational symptoms such as craving for alcohol, which promotes relapse and
alcohol seeking. Understanding how alcohol withdrawal changes brain physiology is an important
step towards developing effective treatments to reduce alcohol abuse. The ventral tegmental area
(VTA) is an important brain area that projects to components of the extended amygdala, including
the nucleus accumbens, prefrontal cortex, amygdala and hippocampus. Changes in the
physiology of VTA neurons induced by withdrawal may underlie the alcohol-seeking during AUD.
The sensitivity of neurons of the VTA to inhibition by gamma aminobutyric acid (GABA) is
decreased during alcohol withdrawal but is normalized by histone deacetylase (HDAC) inhibitors,
indicating epigenetic changes induced by withdrawal in the VTA may be amenable to
pharmacological manipulation. Whole genome sequencing and molecular studies of this project
identified clusters of genes associated with cholesterol synthesis pathway enzymes that were
downregulated and genes for neuroimmune factors that were upregulated during withdrawal. The
proposed project plans to extend our findings to characterize the specific cell types of the VTA in
which these withdrawal-regulated genes are located and how they affect withdrawal-induced
phenotypes of morphology, electrophysiology, and behavior. By using state-of-the-art techniques
of 10x genomics, 3-D electron microscopy, spatial transcriptomics, electrophysiological,
behavioral, and cutting edge molecular biological methods, we anticipate achieving the following
goals: 1) to characterize the epigenetic mechanisms controlling upregulation of neuroimmune
gene expression during withdrawal, 2) to use single nucleus (sn)RNA-seq and snATAC-seq to
determine cell-specific differential expression of genes and chromatin accessibility for selected
genes in the VTA during withdrawal, and to validate the cell-specific expression with spatial
transcriptomics, immunohistochemistry, and chromatin immunoprecipitation, 3) to use CRISPR-
dCas9 plus single guide RNA with cell-specific promoters to prevent withdrawal-induced alteration
of gene expression in specific cell types and determine how this prevention alters withdrawal-
induced phenotypes. Ultimately, these studies are needed to understand epigenetic adaptation
of VTA neurons involved in the positive affective state during alcohol withdrawal, and, with the
other components of this Center, will provide a great deal of information on epigenetic
mechanisms involved in withdrawal-induced brain changes, and possible pharmacological
approaches toward more effective treatment of AUD.

Public health relevance
Relevance/Project Narrative Alcohol use disorder (AUD) is a debilitating disease that is estimated to cost more than $20 billion per year in health care costs and produces untold suffering. Understanding alcohol- induced changes in the brain can lead to the development of novel therapies that can increase the rate of successful recovery from AUD. These proposed studies will increase our knowledge of specific brain changes caused by alcohol exposure and withdrawal and promise to reveal novel mechanisms by which those brain changes can be reversed.